Understanding and targeting the HIV-expressing reservoir to reduce immune activation

Abstract
Although ART can reduce morbidity and prolong life, it does not cure HIV or fully restore health. Despite
ART, people living with HIV (PWH) continue to have higher average levels of inflammation and immune
activation, which are thought to be a major cause for the higher incidence of diseases in many organ systems
(non-AIDS morbidity) and reduced life expectancy that persist even after years of suppressive ART. While the
causes of immune activation may be multifactorial, it is thought that a major cause is the continued expression
of HIV RNA, protein, and/or virions by subsets of HIV-infected cells. Within the gut, where most infected cells
reside, expression of these viral products likely contributes to dysfunction of the gut mucosal barrier and leakage
of gut microbial products into the circulation, leading to further increases in inflammation and immune activation.
However, it is not clear which viral products contribute to immune activation and the sequelae of treated HIV. To
investigate this question, aim 1 will utilize stored and prospective samples from a cohort of ART-suppressed
PWH to determine the degree to which low-level plasma HIV RNA, levels of different cell-associated HIV
transcripts of varying maturity, and p24 protein expression in blood and gut correlate with the inflammatory
proteome in plasma. It is also unclear what subsets of cells express these viral products, and what factors
determine whether a given infected cell will express HIV. To answer these questions, aim 2 will utilize novel
single cell approaches to characterize the cell phenotypes, chromatin accessibility, transcriptomes, clonotypes,
and surface protein expression of single HIV-infected (HIV DNA+) and HIV-transcribing (HIV RNA+) cells from
the blood and gut of ART-suppressed PWH (aim 2A), and will then test how genes identified through single cell
RNA-seq (scRNA-seq) affect HIV expression (aim 2B). While HIV researchers have identified some drugs that
can inhibit HIV transcription, there is a critical need for new therapies aimed at reducing HIV expression and/or
blocking reactivation from latency. We have identified new drugs that appear to block activation-induced
increases in HIV transcription and virion release. In aim 3, we will compare both published and new drugs for
their ability to enhance baseline blocks to HIV transcription or prevent activation-induced reversal of the blocks
to HIV transcription and splicing in cells from the blood and gut of HIV-infected individuals. The results from
aims 1-3 could lead directly to the identification of new drug targets and new agents aimed at a functional cure
and/or reducing HIV-associated immune activation.

Public health relevance
Project Narrative: Despite many years of treatment with existing medicines for HIV (Human Immunodeficiency Virus) infection, HIV-infected cells survive in the blood and tissues (especially gut), and some continue to produce viral products (HIV RNA, protein, and/or viral particles), which cause inflammation, damage multiple organs, reduce life expectancy, and allow the virus to relapse when treatment is stopped. In this proposal, we will apply novel technologies to cells from people living with HIV to determine the viral products that are associated with inflammation, characterize the cells that produce viral products, investigate the mechanisms that determine whether an infected cell will produce viral products, and compare the efficacy of existing and new drugs that are designed to inhibit production of HIV RNA and viral particles. Findings from these studies will generate a wealth of new knowledge and may lead to new approaches aimed at curing HIV or improving the health of people living with HIV.